Evaluating the role of branched chain amino acid transporters in Clostridium perfringens-induced gas gangrene in diabetic and normal mouse models

Project Summary
Clostridium perfringens type A strains cause 80-90% of all cases of gas gangrene (clostridial myonecrosis),
which involves infection of muscle. Gas gangrene is nearly 100% fatal unless promptly treated, which often in-
volves amputation of limbs. Even with treatment, this infection still causes 67% mortality in diabetics. However,
only a small percentage of wounds infected with C. perfringens progress to gas gangrene, highlighting the im-
portance of host factors in this disease. A well-recognized host risk factor for gas gangrene is type 1 or 2 diabetes.
The basis for the association between C. perfringens gas gangrene and diabetes is incompletely understood.
However, we detected strongly upregulated expression of the C. perfringens brnQ2 gene encoding a branched
chain amino acid (BCAA) transporter when a type A strain was co-cultured with C2C12 differentiated muscle
cells. We hypothesize that this observation helps to explain why diabetics are more prone to develop gas gan-
grene. This hypothesis is supported by additional facts. First, C. perfringens cannot synthesize its own BCAAs
so, to grow, this bacterium must obtain these amino acids from the host using a BCAA transporter(s). Second,
clinical studies found that diabetics (both type 1 and type 2) have elevated BCAA levels in their blood and, likely,
muscle cells. Therefore we postulate that, during gas gangrene (particularly in diabetics), C. perfringens growing
in muscle uses a BCAA transporter(s) to take-up BCAAs from blood and/or toxin-damaged muscle cells.
To test our hypothesis and identify which BCAA transporter(s) are important for C. perfringens growth and
survival in gas gangrene-relevant environments, Aim 1 will evaluate C. perfringens growth and survival in gas
gangrene-relevant blood or the presence of toxin-damaged differentiated C2C12 muscle cells. First, C.
perfringens type A strain ATCC3624 null mutants unable to produce the toxins involved in gas gangrene (i.e.,
perfringolysin O and alpha toxin) will be compared against wild-type ATCC3624 for their growth/survival using,
and ability to release BCAAs from, C2C12 cells. If viable bacterial numbers and BCAA release are less for the
toxin mutants, they will be complemented and re-assayed to rule out secondary mutation effects. Aim 1 will then
use the brnQ2 null mutant and a complementing strain to assess BrnQ2’s role in BCAA uptake and its importance
for ATCC3624 growth/survival using blood or toxin-damaged C2C12 cells. Similar studies will be performed
using ATCC3624 mutants unable to produce brnQ or brnQ3, which encode the other two BCAA transporters of
C. perfringens. Aim 2 will evaluate whether BKSdb/db mice (a mouse model for type 2 diabetes that has high
blood BCAA levels) are more susceptible than normal mice for developing gas gangrene. This Aim will then use
the Aim 1 BrnQ-family null mutants and complementing strains to identify which of those BCAA transporter(s)
are important contributors to gas gangrene in diabetic and/or normal mice. If our hypothesis is verified, and a
BCAA transporter(s) involved in gas gangrene virulence is identified, that BCAA transporter(s) could be a
potential target for inhibitor development that could improve gas gangrene therapy.

Public health relevance
Project Narrative Clostridium perfringens requires branched chain amino acids (BCAAs) for growth and we have shown that contact of this bacterium with a differentiated muscle cell line upregulates expression of the C. perfringens gene encoding the BCAA transporter BrnQ2, so we will use BCAA transporter or toxin null mutants to test if a BCAA transporter(s) is important for C. perfringens growth using BCAAs in blood or toxin-damaged muscle cells. Furthermore, diabetics have elevated blood BCAA levels, so we will use BCAA transporter mutants in normal and diabetic mice to test whether BCAA transporter(s) is/are important contributor(s) to the association of C. perfringens-mediated gas gangrene with diabetics.